Engineering fluorescence and magnetic resonance reporter genes for imaging biological function in hypoxic cells and in vivo

Project Summary
One of the most powerful approaches for studying biological function relies on the use of genetically encoded
light-emitting proteins to visualize cell physiology. However, existing reporter genes - the prototypical green
fluorescent protein (GFP) and luciferase − have two major limitations. First, oxidation by molecular oxygen is
central to the mechanism by which GFP, luciferase, and derivative reporters emit light. Second, optical photons
are scattered and absorbed by opaque tissue, which effectively blocks light penetration in intact animals. As a
result, GFP and luciferase based reporters fail to produce light in complex settings such as hypoxia (oxygen <
1%) or deep inside intact animals. An immediate impact of these shortcomings is on medical research. Hypoxia
plays a central role in the pathophysiology of tumors and polymicrobial infections with consequences ranging
from drug resistance to inflammation. To understand how hypoxia reprograms cell function in these contexts,
there is a need for reporter gene technologies that allow biological activity to be dynamically studied in hypoxic
cell cultures. Likewise, to understand processes such as tumor biology in their important in vivo context, there
is a need for reporter genes that are compatible with optically opaque animals. The goal of our research program
is to address these long-standing challenges in biological imaging. To do so, our research will pursue the
development of new classes of reporter genes for noninvasive imaging of biological function in hypoxic cell
cultures (in vitro) and in live animals (in vivo). Our proposed approach builds on proteins with special properties
– photoreceptors, paramagnetic enzymes, and water channels – and applies molecular engineering to develop
new reporters for fluorescence and magnetic resonance imaging (MRI). Our research program proposes five core
objectives: 1) engineering bright, multi-colored, oxygen-independent fluorescent proteins for hypoxia, 2)
developing sensitive and multiplexable MRI reporters for in vivo imaging, 3) designing bioresponsive sensors
based on these proteins to detect cell metabolites and gene expression, 4) applying these sensors to study
antibiotic tolerance in hypoxic bacteria, and 5) induction of specialized treatment resistant cancer cells in
glioblastoma tumors. Success in these goals will provide a breakthrough technique for studying a broad spectrum
of biological processes where hypoxia and in vivo milieu provide important pathophysiological contexts.

Public health relevance
Project Narrative The proposed research will develop a new class of genetically engineered reporters to study biological function in hypoxic conditions and in live animals using fluorescence and magnetic resonance imaging (MRI). These reporters will be applied to study two important biological processes including the development of antibiotic resistance in bacteria and induction of chemoresistant cancer cells in brain tumors. Ultimately, the proposed technologies are expected to promote a deeper understanding of cell function in clinically significant hypoxic and in vivo systems, potentially stimulating the development of targeted approaches to diagnose and treat various human diseases.